RNA polymerase II Elongation Complex: Structure and Function

DESCRIPTION (provided by applicant): Transcription elongation and termination by RNA polymerase II are complex processes that determine the fate of the primary transcript thereby regulate gene expression. A picture is emerging in which there is more than one mode of transcription termination. This has been best examined in the yeast Saccharomyces cerevisiae. In the two conditions, different sets of proteins are involved depending upon RNA sequence signals and the primary transcript's length. In one striking example, conditional transcription termination of a non-coding RNA upstream of the IMD2 gene regulates the expression of IMP dehydrogenase, IMD2's protein product. RNA polymerase II's selection of an initiation site and TFIIB, are implicated in this process. The goal of this project is to elucidate the details of this regulatory strategy and to dissect the requirements by which RNA polymerase II chooses a termination mechanism. IMD2 serves as a useful model to understand and unravel the different mechanisms of termination. Regulation of this gene by nucleotides is seen in organisms from yeast to humans and IMP dehydrogenase is a biomedically important enzyme. Mutations in human IMPDH are linked to retinitis pigmentosa. Small molecules that inhibit it are effective drugs in wide use as valuable immunosuppressants in organ transplant recipients. This proposal will investigate the basic mechanisms of transcription initiation and termination by RNA polymerase II that allow guanine regulation of yeast IMD2. This includes the sliding search for initiation sites by pol II, the interaction of initiator and terminator regions of chromatin, the coupling of termination to exosome degradation of non-coding RNAs, and the activity of the putative helicase Sen1 in yeast and Setx in humans. The human ortholog of SEN1, SETX, is of biomedical importance since its dysfunction results in the neurodegenerative diseases Ataxia and Ocular Apraxia (AOA) type 2 and Amyotrophic Lateral Sclerosis (ALS) type 4. Unraveling this protein's biochemical and biological function will be important for understanding the pathophysiological basis of these diseases. PUBLIC HEALTH RELEVANCE: Project Narrative The cellular machinery that decodes (transcribes) genetic information is complex and its failure to function properly leads to a number of human diseases. This project uses a model organism in which genes, and this so-called transcription machinery, can be experimentally manipulated and will unravel the details by which genetic information is expressed. The parts of the transcription machinery studied here are involved in neurological, visual, and immunological diseases.

Public health relevance
Project Narrative The cellular machinery that decodes (transcribes) genetic information is complex and its failure to function properly leads to a number of human diseases. This project uses a model organism in which genes, and this so-called transcription machinery, can be experimentally manipulated and will unravel the details by which genetic information is expressed. The parts of the transcription machinery studied here are involved in neurological, visual, and immunological diseases.